COVID-19 comorbidity studies in Syrian hamster models

PROJECT SUMMARY
The pandemic SARS-CoV-2 (severe acute respiratory syndrome coronavirus 2) virus can cause severe and
even fatal infections in some patients, primarily those with comorbidities such as hypertension, diabetes mellitus,
obesity, and cardiovascular disease. In addition, immunocompromised patients are also at a high risk of severe
COVID-19, the disease caused by SARS-CoV-2. Animal models are vital for the testing of preventative and
therapeutic approaches to COVID-19, but models that recapitulate the major comorbidities associated with
COVID-19 are lacking. Recently, we established Syrian hamsters as a robust animal model for COVID-19
research. Building on our work with this model, we here plan to develop and evaluate diabetic (Aim 1), obese
(Aim 2), cardiomyopathic (Aim 3), and immunocompromised (Aim 4) Syrian hamsters for COVID-19 research.
For Aim 1 (‘To evaluate diabetic Syrian hamsters for COVID-19 research’), we have already demonstrated our
ability to generate diabetic Syrian hamsters by treating them with streptozotocin, a drug commonly used to
establish diabetic animal models. A high-fat diet will be used to generate obese hamsters for studies in Aim 2
(‘To establish obese Syrian hamsters for COVID-19 research’). Studies in Aim 3 (‘To evaluate cardiomyopathic
Syrian hamsters for COVID-19 research’) will be conducted with BIO14.6 Syrian hamsters, an established
cardiomyopathic disease model. An immunocompromised status will be induced by treating animals with
cyclophosphamide (a drug commonly used to induce immunosuppression) for studies in Aim 4 (‘To establish
immunocompromised Syrian hamsters for COVID-19 research’). Specific markers, such as blood glucose levels
(for diabetes), leptin levels (for obesity), troponin T levels (cardiovascular injury) and leukocytes counts (for
immunosuppression) will allow us to monitor the disease states. Animals will then be infected with SARS-CoV-
2, and virus titers in different organs will be measured at different timepoints post-infection. In addition, we will
measure the duration of virus shedding and the efficiency of virus transmission, both of which may be increased
in co-morbid compared with healthy SARS-CoV-2-infected animals. We will also assess the susceptibility for
reinfection with SARS-CoV-2 of both healthy and co-morbid Syrian hamsters. The comorbidities tested here
result in chronic inflammation and/or impaired immune responses. Therefore, the levels of several pro-
inflammatory cytokines and antibodies to SARS-CoV-2 in serum samples from these hamsters will be evaluated.
Collectively, we will establish and test several Syrian hamster comorbidity models for SARS-CoV-2 research.
Our data should provide a solid platform for the use of co-morbid Syrian hamster models in the testing of vaccines
and antiviral compounds for SARS-CoV-2.

Public health relevance
PROJECT NARRATIVE There is need for animal models that mimic the major comorbidities associated with severe COVID-19, such as diabetes mellitus, obesity, and cardiovascular disease. Immunocompromised individuals are also at a high risk of developing severe COVID-19. Here, we plan to establish and evaluate diabetic, obese, cardiomyopathic, and immunocompromised Syrian hamsters in COVID-19 studies; these animal models will be useful to test vaccines and antivirals for use in SARS-CoV-2-infected patients with these comorbidities.